Mechanosensitive Mechanisms of Premature Calcification in Bicuspid Aortic Valve Disease

PROJECT SUMMARY
Bicuspid aortic valve (BAV) disease is the most prevalent congenital heart disease, affecting ~2% of the
population worldwide. This disorder is characterized by the formation of two, rather than three valve cusps,
leading to narrowing of the valve opening and increased mechanical stress. The structural defect is not what
requires clinical intervention, but rather the development of premature calcific aortic stenosis (CAS) in ~50% of
BAV patients. The association between BAV-induced mechanical stress and premature CAS is poorly
understood, resulting in medical treatment options that for severe CAS, is currently limited to surgical aortic valve
(AoV) replacement with associated complication. Therefore, there is a critical need to mechanistically determine
if, and how BAV-induced mechanical stress promotes early onset calcification at molecular and cellular levels.
The pathobiology of BAV-related premature calcification in young adults is poorly understood, although
collective reports suggest that abnormal mechanical stress induced by the structural malformation of the AoVs
play a role; however, this has not been directly investigated. Therefore, a major goal of my research is to address
this using mouse models of human disease integrated with innovative in vitro assays and molecular biology
techniques to enhance my training. The foundation for this work was initiated by previous studies in the lab that
performed computational modeling in parallel with spatial transcriptomics to correlate regions of high mechanical
stress with activation of a calcification gene expression program. My more recent preliminary data further shows
that these regions also associate with enrichment of differentially expressed genes that associate with ‘ATP-
metabolic processes’, including increased expression of ATP purinoreceptor, p2rx4, that I have shown to be
required for expression of calcification genes in valve interstitial cells. Based on these data and additional
preliminary studies, I hypothesize that BAV-induced mechanical stress leads to VEC-mediated ATP release, that
acts upon p2rx4 in VICs, initiating pre-calcific molecular changes. To test this, I will perform two specific aims:
Aim 1. Delineate the BAV-specific mechanosensitive signaling pathway between VECs and VICs that promotes
early onset calcification. Aim 2. Determine if p2rx4 antagonism can prevent and treat premature calcification in
mouse models of BAV. Outcomes from these studies will provide substantial insight on the relationship between
biomechanical stress and molecular changes in the valve, while also identifying a potential target for therapeutic
drug development, to prevent the onset of CAS in BAV patients.

Public health relevance
PROJECT NARRATIVE Bicuspid aortic valve disease is the most prevalent congenital heart defect, in which 50% of patients develop premature calcification and associated stenosis during early adult life. It’s believed that alterations in mechanical stress on the aortic valve as a result of the congenital malformation, may contribute early calcification; however, the mechanisms are not known. This proposal aims to understand this and identify the signaling pathway that relays abnormal biomechanical stress received by valve endothelial cells, to underlying valve interstitial cells to promote a calcification program.